FunGen-xQTL: Unraveling the genetic basis of molecular functions in Alzheimer's Disease

Project Summary
In this project, we propose to identify causal genes, cell types, and molecular mechanisms in Alzheimer’s disease
(AD) by leveraging genetics as natural perturbation experiments across multi-omics data — a unique approach
to establish causality in human brain samples where experimental manipulation is not possible. Building upon
the successful pilot phase of the ADSP Functional Genomics Consortium xQTL Project (FunGen-xQTL), we
integrate multi-ancestry molecular quantitative trait loci (xQTL) across brain cells, cerebrospinal ﬂuid (CSF), and
blood to address key challenges in AD genetics: determining causal relationships between brain and blood
regulation, identifying disease-relevant cell contexts, and bridging the gap between GWAS ﬁndings and molecular
mechanisms. Our approach combines deep molecular proﬁling of understudied brain cell populations with
advanced computational methods across four speciﬁc aims: (1) Generating and ﬁne-mapping molecular QTL in
rare brain cell types across ancestries, with unprecedented proﬁling of 450 African Americans and 350 Hispanic
individuals; (2) Integrating xQTL data from brain, CSF, and blood to uncover coordinated neurovascular regulation
and causal relationships between tissues in AD; (3) Developing advanced computational methods including
AI-powered prediction and causal multi-context analysis to identify disease-causing genes and their relevant
cellular contexts; and (4) Investigating molecular mechanisms of prioritized targets through systematic functional
studies using human iPSCs. The impact extends beyond creating a comprehensive multi-ancestry xQTL resource
– our systematic approach to disentangle complex regulatory mechanisms will establish precise cellular and
molecular targets for therapeutic development in AD and related dementias.

Public health relevance
Project Narrative The FunGen-xQTL Project aims to reveal how genetic variants cause Alzheimer’s disease (AD) by studying their effects across different brain cell types and ancestral populations, with particular focus on understanding coordinated regulation between brain and blood. Using cutting-edge experimental and computational approaches, including artiﬁcial intelligence and deep molecular proﬁling of 40,000 brain cells per sample, we will identify speciﬁc genes and cell types that drive AD risk. This work will particularly beneﬁt underrepresented populations through extensive proﬁling of African American and Hispanic individuals, while uncovering new therapeutic targets and providing crucial resources for the broader AD research community to develop more effective, population-speciﬁc treatments.